Antibody Mediated Immunity Against Brucella

Abstract:
No vaccines are currently licensed to prevent human brucellosis and existing vaccines for
livestock are not entirely efficacious. In humans and other animals, Brucella can cause a lifelong
infection. However, mechanisms underlying the ability of Brucella to subvert adaptive immunity
remain unclear. In this proposal we show that vaccine elicited antibodies alter host metabolism to
protect the host against Brucella to some degree. Therefore, in Specific Aim #1 of this proposal
we will determine how vaccine-elicited IgM and class switched antibodies alter tissue metabolism
to restrict Brucella infection. We also found that Brucella encodes virulence factors that mediate
evasion of humoral immunity. Therefore, in Specific Aim #2 of this proposal we will identify
mechanisms by which Brucella subverts antibody mediated immunity. Collectively, our results will
enhance our understanding of how current vaccines protect the host, and how Brucella is able to
subvert adaptive immunity, and thus could improve the rational design of highly effective vaccines
for Brucella.

Public health relevance
Project Narrative: No vaccines are currently licensed to prevent human brucellosis and existing vaccines for livestock are not entirely efficacious. However, mechanisms underlying the ability of Brucella to subvert vaccine-mediated immunity remain unclear. In this proposal, we will investigate both how vaccines alter metabolism to protect the host, and how Brucella is able to evade adaptive immunity, which therefore could improve the future rational design of highly effective vaccines against Brucella.